Parent-directed remote identification and severity assessments enabling decentralized trials in atopic dermatitis

PROJECT SUMMARY
Recent studies reveal up to half of children with childhood onset atopic dermatitis (AD) may remit
over time, whereas in others, AD worsens with age. AD in childhood often heralds the development of
subsequent comorbidities including asthma, food allergies, skin infections and neurodevelopmental
disorders. It is not known whether the timing or type of treatment for AD alters the natural course of
the disease or modifies the risk of comorbidity development. Therapeutic strategies that prevent or
alter the natural course of AD represent the highest priority research gap as identified by the
International Eczema Council in 2021. This gap aligns with the overarching long-term goal of our
research team to identify and test interventions that prevent the overall burden of AD and
comorbidities in broad and diverse communities. The overall objective of this application, as a critical
step towards our long-term goal, is to develop tools that facilitate patient-centered decentralized
clinical trials investigating the role of early intervention on disease course and comorbidity risk. We
will achieve this objective by completing the following aims: Aim 1) Determine the feasibility and
accuracy of identifying new-onset AD remotely in a community-based high-risk pediatric cohort using
parent/guardian-reported validated diagnostic criteria with photographic documentation using a novel
mobile application; and Aim 2) Determine the accuracy of parent/guardian report of AD severity using
an image-based assessment of skin lesions in order to efficiently measure disease severity over time.
These tools will be utilized in future decentralized trials of early therapeutic intervention. Our
established community-based clinical trial network, central study team infrastructure, and
decentralized study design expertise allow for increased efficiency in enrollment and improved
generalizability of results as compared to traditional approaches – two factors that will ensure the
success of this proposed project.

Public health relevance
PROJECT NARRATIVE Decentralized clinical trials are a new form of clinical study designed to expand access to studies and reduce the burden on study participants by using technology, such as mobile phones, to collect data from home. This study creates a new way to identify new onset atopic dermatitis (eczema) and grade the severity of the skin condition using a mobile phone by parents or guardians. This will allow a more patient-centered approach to testing the best ways to treat and prevent eczema and allergies – a significant global health problem.